Bridges to the Baccalaureate Research Training Program at University of Alabama at Birmingham

Biomedical research is expanding rapidly in the US; however, minorities continue to be
underrepresented in this workforce, constituting ~29% of the US population, but receiving only
~7% of PhD degrees and only ~4% of NIH RO1 grants. Many minority students lack early
engagement and opportunities to develop skills and content knowledge to complete BS programs.
For over 10 years Jefferson State Community College (JSCC) and the University of Alabama at
Birmingham (UAB) have partnered to develop a dynamic program to bridge minority
JSCC students into undergraduate and graduate biomedical and behavioral education and
careers. Our current Bridges to Biomedical Careers grant (BBC) predicted that 75% of students
would gain a BS in 5 years, 35% would enter biomedical graduate education and 35% would
enter biomedical careers. Of the 95 students in BBC, 98% have completed or are currently
completing a BS in biomedical/behavioral sciences in 5 years or less, 100% are minorities,
and 75% are in (or applying for) biomedical and behavioral graduate programs. The
remaining 25% are pursuing research careers with their BS. One of the greatest challenges for
students in BBC has been their need to work during the school year to pay for their tuition,
decreasing the time they could work on their research. The new NIGMS B2B program
addresses this challenge by funding students to carry out research throughout the entire year,
starting with a summer research internship in their rising sophomore year. Bridges-UAB
takes advantage of this greater student funding to enhance student success even further. It
will include a very rigorous recruitment of freshman students at JSCC, including a research
workshop and intro to research course and develop other JSCC and UAB partnership
biomedical courses. Bridges-UAB will promote closer interactions between JSCC and UAB in
research and education and provide students at JSCC and UAB with educational opportunities,
internships and mentoring that will immerse them into biomedical and behavioral research
and prepare them for research careers. Bridges-UAB will provide scholarships to
cover the sophomore and junior years, and UAB plans to cover most senior year costs, thus
paving the way for the students to focus on learning and their cutting-edge research. Upper-
level students will be encouraged to be peer mentors to newer students, and top Bridges-UAB
students will return to present their research at JSCC in the workshop and other courses,
encouraging the JSCC students to consider research careers. The Broader Impact will be to
expand the diversity of the biomedical research workforce. The Intellectual Merit will be to identify
methods that engage and prepare minority students for careers in biomedical research.

Public health relevance
To increase the pathways for URM students to reach graduate biomedical training, Bridges-UAB will initially focus on the transition and initial biomedical education of students into Jefferson State Community College (JSCC) and then the transition to rigorous laboratory research and training at the University of Alabama at Birmingham (UAB). Bridges-UAB will offer 10 JSCC students each year the opportunity to pursue biomedical and behavioral research under the tutelage of world-class, funded researchers and educators, so that working in research teams, the students will conduct discovery research that they design in concert with their research mentor, thus advancing their research skills and knowledge of biomedical and behavioral sciences and helping them to decide a direction for their careers. In addition to the research mentors, more senior Bridges-UAB students and graduate students will serve as peer mentors to ensure that Bridges-UAB students have a smooth transition into biomedical courses at JSCC, into successful research at UAB and career success.